P311 mediated adipogenesis, adipocyte plasticity and metabolic regulation

Summary
One third of the US population is clinically obese, a condition which increases the risk for chronic diseases like
type 2 diabetes mellitus (DM), heart disease and cancers. Adipocyte dysfunction (AD) is cardinal feature of
metabolic dysregulation and increases the risk for developing insulin resistance (IR), DM, and hypertension.
Along with adipocyte hypertrophy, macrophage infiltration of white adipose tissue (WAT) is associated with the
pathophysiology of obesity, AD and IR, albeit the underlying molecular mechanisms are uncharacterized. We
were first to show the presence of P311 in WAT, brown adipose tissue (BAT) and beige adipose tissue. The
WAT of P311 knockout (KO) mice has fewer resident macrophages and decreased cellular dynamics,
including decreased autophagy and apoptosis. This is potentially leading to adipocyte hypertrophy that in turn
causes hyperglycemia due to age- and genetic ablation-mediated P311 expression leading to overworked and
exhausted adipocytes in P311 KOs or low P311 expressing adipocytes compared to wild types. As studies are
limited, resident macrophages could alter adipocyte function early in adipose tissue development, a novel
mechanism requiring exploration. We will also explore key adipocyte cellular processes of apoptosis and
autophagy/lipophagy, which may affect adipocyte turnover in the WAT of P311 KO mice, leading to adipocyte
hypertrophy and dysfunction, and thus metabolic deregulation.
The proposed project will test the central hypothesis that age- and genetic ablation-mediated P311 levels play
a key role in white, brown and beige adipocyte development, plasticity and function, as well as in metabolic
regulation. Further, we will investigate the role of P311 in cellular processes (i.e., WAT browning and BAT
whitening) and its effect on adipocyte function and glycemic control, as P311 KO mice are hyperglycemic. We
will also evaluate the ability of P311 to modulate adipose biology and metabolic regulation through PPAR and
UCP1 regulation; and myo1C binding to GLUT4. We will develop adipocyte-specific P311 KO conditional mice
using novel CRISPR technology to evaluate the adipocyte-specific P311 roles. The current project will thereby
establish P311 as a new player in adipocyte biology and metabolic regulation. Our experimental strategy will
incorporate transgenic animals using classic cell biology, molecular biology, biochemical, immunoassays and
imaging methods studies. Our findings will enhance the understanding of P311 mediated fat cell development
and function and fat mass expansion. Our ongoing studies indicate that P311 potentially regulates metabolism
through adipocyte dynamics, function and plasticity (a novel approach to targeting metabolic disorders through
browning of WAT); regulating resident and infiltrating macrophages; and controlling adipocyte cellular
processes. These studies are new and do not overlap with existing funding.

Public health relevance
Project Narrative My research is focused on understanding the role of P311, a small protein that regulates the development, plasticity (switch among different types), and function of different types of fat cells (white, beige and brown). The goal of this research is to understand how this protein controls fat cells to influence the development of related metabolic diseases, such as diabetes. Knowing how P311 works can help us to develop novel strategies towards developing treatments for obesity and associated metabolic irregularities.